Use of Multifunctional rhPRG4 Biologic for Treatment of TBI

PROJECT SUMMARY Traumatic brain injury (TBI) is a devastating medical condition that affects more than 1.7 million civilians in the US and represents an unmet clinical need. Effective therapies are urgently needed, as TBI is associated with high rates of hospitalization, mortality, and disability. Previous clinical trials have failed to demonstrate thera- peutic efficacy in patients with TBI. This project focuses on evaluating the therapeutic efficacy of a novel multifunctional biologic—recombinant human proteoglycan 4 (rhPRG4), also known as lubricin—in TBI. rhPRG4 effectively interacts with both hydrophilic and hydrophobic surfaces, and has strong anti-adhesive and anti-inflammatory properties. When administered peripherally in a rat model of TBI, rhPRG4 crosses the blood-brain barrier (BBB) in the injured brain parenchyma, but is absent from the uninjured parts of the brain. Our preliminary data show that rhPRG4 dramatically decreases the post-traumatic production of proinflammatory mediators and matrix metallo- proteinases, and reduces the influx of inflammatory cells into the injured brain parenchyma. rhPRG4 also has a unique ability to stabilize the BBB, whose function is affected by TBI. These observations suggest that the rhPRG4 biologic could limit the destruction of neural tissue observed in TBI and, consequently, improve neurological outcome after injury. There are two major goals of this study: (1) to assess the efficacy of rhPRG4 in engaging with its putative targets and enhance our understanding of rhPRG4's ability to stabilize the BBB in acute phase of injury, and (2) to obtain preclinical data on long-term efficacy of rhPRG4 in reducing the neuronal loss and improving functional outcome after TBI.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) affects an estimated 1.7 million civilians in the US each year. Prognosis largely depends on the severity of secondary injury processes that result from the impact; patients who recover often exhibit long-lasting disability that invariably includes memory loss and deficits in executive functions. The objective of the proposed studies is to test the therapeutic efficacy of a new multifunctional rhPRG4 biologic, which is expected to curtail neuronal death and facilitate functional recovery after TBI.